Physical Activity in Transition-Age Youth on the Autism Spectrum

PROJECT SUMMARY/ ABSTRACT
The long-term goal of this K23 Career Development Award is to prepare the PI (Yu-Lun Chen, PhD)
for an independent research career that aims to promote physical activity (PA) and health in people
on the autism spectrum, with a focus on transition-age youth on the spectrum (TAYS). PA, defined as
any bodily movement increasing energy expenditure above a basal level, is critical in promoting
physical and mental health and preventing adverse health conditions. However, TAYS are four times
less likely to achieve the recommended PA levels than typically developing peers. This is a significant
health concern for TAYS that not only diminishes their quality of life but also correlates with a nearly
doubled risk of obesity compared to the general population. Inactive lifestyles in TAYS likely persist
into later adulthood and may increase risks for chronic diseases in later adulthood. For instance,
adults on the spectrum face more than doubled risks of type 2 diabetes and cardiovascular diseases
compared to the general population, suggesting an urgent need to promote PA in TAYS and avert
negative health outcomes. However, high-quality PA interventions for TAYS are scarce due to key
knowledge gaps including a lack of validated, objective outcome measures of PA behaviors in TAYS,
as well as limited scientific knowledge on the modifiable factors unique to TAYS that are associated
with PA and can serve as potential intervention targets. The K23 research will address these through
the following aims: 1) to calibrate and validate wrist accelerometer output of PA measures to account
for repetitive hand movements in TAYS; 2) quantify patterns of PA behaviors in TAYS in everyday life;
and 3) identify modifiable intervention targets for PA by systematically assessing predictors of daily PA
behaviors including functional impairment, contextual barriers, and motivation. The proposed K23
research project will generate novel data on PA outcome measures, patterns of PA behaviors, and
modifiable targets for intervention for TAYS, enabling the development and evaluation of a high-quality
PA intervention in subsequent R21 and R01 proposals. The proposal expands the PI’s prior training in
health outcomes research with TAYS to develop an innovative research program in PA promotion, a
critical yet understudied topic. The K23 training plan involves PA measurement validation,
accelerometry data analysis, and community-engaged PA intervention development. The K23
mentoring team has extensive mentoring experience, multidisciplinary expertise directly relevant to
the proposal, and a history of productive collaboration with the PI. By the end of the training, the PI will
be able to incorporate wearable accelerometer measures in mobile-health PA research and develop
an independent research program on health promotion in TAYS, ultimately improving well-being and
preventing chronic health conditions in these vulnerable populations.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Four in five youth on the autism spectrum do not engage in sufficient physical activity (PA), which is linked to increased risks of major chronic diseases such as type 2 diabetes and cardiovascular diseases in later adulthood. This study will help advance intervention development to promote PA in transition-age youth on the autism spectrum, by validating an accelerometer-based outcome measure, quantifying health-enhancing physical activity behaviors, and identifying potential intervention targets. The findings and data of this study will directly inform a targeted intervention addressing the PA barriers unique to this population and enable accurate evaluation of intervention outcomes, contributing to improving PA and health outcomes in people on the autism spectrum.